PIPELINE Facility Core

SUMMARY: PIPELINE FACILITY CORE
The Vision for the PIPELINE (Promoting Impact of Precision EHS by Leveraging Instrumentation,
NextGen and Emerging Technologies) Core is to provide access to expertise and technologies, and
facilitate effective utilization of “omic” technologies across the parent organizations of the GC-CPEH to
advance environmental health science (EHS) research. The PIPELINE Facility Core provides efficient
systems level access, enabling researchers from all Thematic Focus Areas to incorporate multiple NextGen
“omics” technologies into their research. PIPELINE provides services in 1) Genomics, Epigenomics and
Transcriptomics, 2) Proteomics, 3) Metabolomics, 4) Microbiome and Metagenomics, 5) Cells-to-Tissues-
to-Organisms and 6) MultiOmic Data Analysis. To support utilization, the PIPELINE Facility Core 1) provides
consultation to Center members to identify the best state-of-the-art technologies to meet their research goals; 2)
works with members to ensure efficient project design and comprehensive data generation; 3) delivers
individualized training, and develops workshops and Resource Educational Sessions; and, 4) provides robust
bioinformatic analyses and data interpretation integrating multiple platforms to ultimately provide systems-level
knowledge. Importantly, resource access and utilization are facilitated by subject-matter experts serving as
Resource Navigators for GC-CPEH members. Resource Navigators provide expertise, prioritize access, and
assist members with project design, data generation and bioinformatics analyses. This Core also supports the
educational and mentoring needs of members through individualized training, seminars, workshops, and
participation in the Leadership Development Program of the Center's Career Development Program.
Access and utilization of PIPELINE services is facilitated via a Matching Funds Core Utilization Program,
which significantly reduces the cost of services. The following Specific Aims are designed to ensure the
PIPELINE Facility Core achieves the goal of advancing EHS research for GC-CPEH investigators and via cross-
Center collaborations, EHS researchers at other EHS Core Centers. Specific Aim 1: Provide high-quality, user-
friendly NextGen resources to accelerate precision environmental health research and increase the impact of
GC-CPEH research; Specific Aim 2: Contribute to the career development of promising new investigators and
enable utilization of new technologies by senior investigators; and Specific Aim 3: Increase the impact of the
GC-CPEH research base by integrating across Center components and institutions and contributing to
exploratory Pilot Project research and high-impact publications.